Disentangling the genetic mechanisms of endometriosis severity with single-cell multi-omics

ABSTRACT
Around 10% of reproductive-age women have endometriosis, but the molecular drivers of this common chronic
gynecologic condition are poorly understood. Endometriosis is a major cause of pain and infertility in women, is
associated with significant financial burden, and multiple comorbidities including pain syndromes, inflammatory
and immune conditions, anxiety, and depression. Staging is commonly used to describe endometriosis in
research and in the clinic, but the biologic underpinnings of each stage are poorly understood. We have
recently performed key studies to map gene expression in endometriosis and endometrioma, uncovering
changes in cell type distribution, gene expression and predicted transcription factor network activities
associated with high or low stage disease. This project will focus on characterizing the epigenome of high and
low stage endometriosis, combining single cell epigenomics and multiome methods with state-of-the-art
analytic methods for dimensionality reduction, allelic imbalance detection and polygenic risk scores. In Aim 1
we will perform large-scale single cell epigenomic profiling to characterize landscapes of disrupted gene
regulation in low and high stage endometriosis; Aim 2 will dissect the allele-specific mechanisms of gene
regulation across endometriosis stages and Aim 3 will develop genetic predictors of outcome in endometriosis.
This project makes use of a large and unique endometriosis cohort study with deep clinical annotation,
longitudinal follow-up and >8000 biospecimens. The collaborative and multidisciplinary team have a track
record in successful collaboration resulting in high-impact research, and are focused on translating the insights
gained to improve diagnostics/screening and/or tools for predicting post-surgical outcomes to help personalize
treatment for endometriosis patients.

Public health relevance
NARRATIVE Endometriosis is a common condition, and there is a poor understanding of the genes and noncoding regulatory elements that drive disease development. This project will combine state-of-the-art single cell epigenomics and multiomics with new analytic methods that leverage germline risk information to identify cell types, regulatory elements and genes involved in disease development and outcomes. These insights are expected to pave the way to the development of personalized risk scores and precision medicine for endometriosis.